Training in Cardiovascular Physiology and Pharmacology

Project Summary Abstract
This proposal is a resubmission of a renewal application that has been supported by NHLBI for nearly four decades.
Support for eight postdoctoral trainee positions is requested in this renewal application, as has been present
during the current funding period.
The overriding goal of our program remains to provide the highest caliber training of postdoctoral trainee
scientists and physician-scientists, to build the pipeline of tomorrow’s cardiovascular researchers. Our trainees
are instilled with expertise so that they can solve cardiovascular problems using multidisciplinary approaches,
as they are mentored by the excellent faculty at University of California, San Diego (UCSD), one of the top
research institutions in the world. The postdoctoral fellows emerging from our rich academic environment are
imbued with the ultimate goal to seek long term success in academia, industry, government, or non-profit sectors.
There is clear continued need for this program since cardiovascular disease remains the leading cause of
death globally, according to the W.H.O., and is also among the top causes of mortality and morbidity in the U.S.
This obligates our program, our institution, and the United States, to train investigators who will advance the
forefront of cardiovascular biomedicine.
No other training mechanisms exist at UCSD that provide support and training of postdoctoral trainees in
the unique and specific cardiovascular disciplines of this grant. The Guiding Principles for the program are
embedded in the rich history of this program and propelled us to maintain our original title of the grant - “Training
in Cardiovascular Physiology and Pharmacology.” Yet, we highlight that this T32 program continuously
evolves and seeks improvement. It provides broad exposure to the study of cardiovascular basic biology,
physiology, disease pathobiology, and related translational pursuits. Primary areas that the program focuses on
are 1) cardiac signaling, 2) cardiac development, regeneration, and stem cell biology,
3) cardiac genetics and epigenetics, 4) cardiac bioengineering, and 5) cardiac clinical and translational focused
biology. Within these areas of focus we foster exposure of the trainees to the most modern, innovative, and
emerging technologies to accelerate their hypothesis driven discoveries. This might include use of human stem
cell-based model systems, omics-based approaches, computational sciences, and big data informatics, and how
best to translate from bench to the bedside. During the success of this T32 program over the last forty years of
continuous support, it has been instrumental in training many of the leaders in cardiovascular biology at UCSD,
and also has had broad impact on producing leaders throughout the country in both academia and industry.

Public health relevance
Project Narrative This proposal is a resubmission of a renewal of a training grant that requests support for eight postdoctoral trainees at UCSD each year. The major objective of our program is to train individuals so that they have a broad- based background in cardiovascular biology. The program provides extensive research and career mentoring of trainees to equip them to become independent investigators, and tomorrow’s cardiovascular leaders.